Promoting Diversity, Inclusion, and Professional Development in the International Behavioral Neuroscience Society

Project Summary
The mission of NIMH is to transform the understanding and treatment of mental illnesses through basic and
clinical research, paving the way for prevention, recovery, and cure. This application proposes to enhance
training, mentorship, racial and ethnic inclusion, gender diversity and expansion of professional development
for trainees and early stage investigators to the annual International Behavioral Neuroscience Society (IBNS).
This proposal seeks to: 1) Provide financial support for trainees and early stage investigators to attend the
annual IBNS meeting. Such funding will provide opportunities to showcase their research, as well as
formalized network and mentee-mentorship opportunities with leading scientists in the field that extend
throughout the trainees’ careers; 2) Continue support of workshops that focus on training, enhancing, and
promoting diversity and inclusion within IBNS, with outreach that goes beyond the annual meeting; 3) Ensure
that the junior women and trainees from underrepresented groups supported by these funds obtain training in
targeting NIMH scientific priorities consistent with the IBNS mission. Given that psychiatric disorders are
categorized by their behavioral abnormalities, it is imperative to determine neural mechanisms underlying such
behaviors, and critically, cross-species biomarkers of behavior. The IBNS since its creation in 1992, has been
at the forefront of investigating behavior and underlying neural circuitry using the innovative neuroscientific
tools integrated with sophisticated behavioral tools in order to: 1) Identify mechanisms of complex behaviors; 2)
Determine potential neural biomarkers of such behaviors; 3) How these mechanisms are affected in disease
states; 4) Target such mechanisms for preventions and cures; and 5) Improve behavioral neuroscience
approaches for rigor and reproducibility and identify sex differences relevant to human behaviors. Given its
international nature, IBNS has also been at the forefront at recruiting diverse viewpoints across science. With
an additional goal for training the next generation of neuroscientists looking to understand and cure diseases,
IBNS provides 20-26 Travel Awards annually, creating a safe space for diverse trainees. With this application,
we wish to promote additional diversity of our travel awardees, as well as fund educational workshops to aid
trainees from undergraduate, graduate, post doctoral (within 5 years), and early stage investigators (within 2
years of faculty appointment. This application therefore requests funding to increase the opportunities for
trainees to attend our 2021 annual meetings.

Public health relevance
Narrative Mental illness effects one-fifth of all U.S. adults and the burden of mental illness is predicted to rise worldwide in coming decades; thus it is critical to improve our understanding of brain-based disorders that are primarily diagnosed by behavioral abnormalities. The International Behavioral Neuroscience Society (IBNS) has long- been dedicated to investigating behavior and underlying neural circuitry using the innovative neuroscientific and behavioral tools to identify the underlying mechanisms of behavioral disorders. This application will provide opportunities to enhance training, professional development, and networks in the behavioral neurosciences by providing support for trainees and early stage investigators to attend the 2021 annual IBNS meeting and workshops at that meeting, as they transition to independent researchers determining the underlying mechanisms that drive behavioral disorders.